RNA homodimerization strand displacement pathways to extended duplexes: Atomistic details for a mechanistic paradigm to identify unique antiviral targets for current and emerging viral pandemics

Project Summary
Kissing complexes (KC) and extended duplexes (ED) represent dynamic RNA structures whose interconversion
is an example of strand displacement reactions that has been implicated in playing vital roles in several viruses,
influencing a broad spectrum of biochemical processes including genome packaging, viral recombination, and
host-pathogen interactions. However, the structural, dynamic, and energetic details on how these
interconversions occur are virtually unknown yet are vital in our novel approach of identifying and characterizing
previously unconsidered meta-stable pathway states to inspire future antiviral and drug resistance development.
Overcoming significant challenges that hamper meaningful modelling of RNA and dimers, and associated
interconversion pathways necessitate judicious choice of computational techniques and integration with
experimental data across physiologically relevant timescales. Our overarching hypothesis is that by leveraging
the limited kinetic and thermodynamic data reported on RNA transition pathway systems, including the human
immunodeficiency virus 1 (HIV-1) dimer initiation site (DIS) and model complexes based on the bacterial E. coli
DsrA-rpoS RNA-mRNA regulatory complex, a general paradigm will be developed for other known RNA
dimerization systems, such as SARS-CoV, SARS-CoV-2, HCV, and future emerging RNA viruses requiring novel
antiviral therapies. To address our hypothesis, we first employ a unique approach to establish the unbiased
structure and dynamics of RNA structures representing both pathway endpoints of each strand displacement
reaction, such as KC to ED (Aim I). Confidence in structural predictions for systems without experimental
structures is engendered by comparing computations against HIV-1 DIS crystallographic structures. We next
apply a minimum energy pathway technique with and without protein chaperones to identify meta-stable states
(Aim II). Reliability of the method is evaluated against the kinetic and thermodynamic data reported for the KC
to ED interconversion for the E. coli DsrA-rpoS RNA-mRNA regulatory complex. Finally, as a proof of concept,
we will screen RNA-binding molecules and antisense oligonucleotides against identified meta-stable
intermediates along the pathways (Aim III). Aligned with NIH/R15 goals, we will train undergraduates to
understand the capabilities, limitations, and errors of experimental and computational chemistry to craft ultimately
a seamless research approach. Our training objective is to deliver a quality research experience that motivates
undergraduates to achieve their highest potential and best prepare them for scientific research and discovery.
The intent is to attract and retain the nation’s diverse student talent pool, having the consequence of enriching
and diversifying the U.S. workforce by adding experts in the field of biomedical chemistry. The expected scientific
outcomes are to unlock novel physical insights into strand displacement reactions and provide a foundation for
targeted drug design and therapeutic interventions for drug resistance of HIV-1, SARS-CoV2, and HCV viruses
of current

Public health relevance
Project Narrative Viral RNA-RNA complexes, such as kissing complexes, extended duplexes, and novel meta-stable states along their interconversion pathways, represent potential pharmaceutical targets to disrupt the lifecycle or immune response of viruses of current public health relevance, e.g., HIV-1, SARS-CoV-2, and HCV, yet the atomistic- level structural details of the possible interconversion pathways are unknown and needed for rational data driven decisions targeting antiviral therapies. The intent of our work is to expand the scope of limited structural, kinetic, and thermodynamic data of RNA-RNA complex interconversion pathways to garner fundamental knowledge on highly conserved structures and sequences to create a paradigm that sets a new avenue for the development of antiviral therapies, drug resistance, and emerging RNA viruses. Ultimately, holistic investment in undergraduate and graduate student training holds the promise to train a new generation of researchers and add to existing knowledge that will enhance health, lengthen life, and reduce illness by providing the possibility for future discoveries of new antiviral therapies.